Administrative and Research Support

Project Summary
This core provides the means for faculty affiliates, pre-doctoral students, post-graduate fellows and academic
staff to carry out research and training on health and aging at various levels in a way that is consistent with the
central mission of the center and the five major themes outlined in the Overall section. The core maintains a
stable and effective system for the administration and allocation of resources to accomplish CDHA’s mission;
manages recruitment of affiliates, postdoctoral fellows, predoctoral students and academic staff; ensures an
efficient administration of resources to provide quick and efficient access to information, data storage and data
access, computing facilities, productive collaboration and synergy among affiliates, timely preparation of
research reports, broad dissemination of CDHA research products, and dynamic search for sources of
extramural funding and support

Public health relevance
Project Narrative Per funding announcement instructions, the narrative is located in the Overall section of this proposal.